Measurement and Analyses Core

Abstract: Measurement and Analysis Core: (AnC)
While conceptualizing the experiences of trauma, those from East Asia (i.e. Cultural Revolution) may have
different experiences than those from South Asia (i.e. Indo-Pakistan War) or those who might have
experienced genocide in South East Asia (i.e. Cambodia). Similar heterogeneity persists in the
conceptualization and operation of resilience, especially in terms of the differential social and cultural
determinants of coping strategies and help-seeking behaviors to buffer the negative outcomes associated with
trauma. In our Measurement and Analysis Core (AnC), we will confront these complexities and leverage the
assembled AnC faculty talent and use mixed-method approaches to rigorously examine trauma and resilience
constructs and subcultural differences across different Asian groups. In addition, we will leverage a multi-level,
ecological, life course model while considering social, intergenerational, and cultural norms, not only through
traditional public health theories, but also guided by the anthropological, sociological, and behavioral theories.
AnC faculty will bring high scientific rigor in their approach as they have deep experience in: developing
and testing measures; quantitative and qualitative research methods; secondary data analyses; harmonizing
large datasets; systems science; sociological, anthropological, health services, and behavioral health
interventions; and implementing research with community partners. AnC will work with RCMAR Scholars to
develop detailed conceptual frameworks applying appropriate theoretical approaches, data gathering
instrument design, and will support analysis and interpretation. The specific aims for the AnC are:1). Support
the identification and acquisition of local, regional, national, and global datasets and to promote and facilitate
the use of these secondary datasets; 2). Advance and disseminate methods for harmonizing and analyzing
data across Asian populations to compare trauma and resilience as it relates to culture and health outcomes;
3) Support the pilot teams in developing, adapting, evaluating, and disseminating analytic frameworks,
culturally sensitive metrics and scientifically robust measures for older Asian populations; 4) Develop
sustainable trainings regarding the research analytics and evaluation pipeline using cross discipline strategies.
5) Build team science across AC, REC, and CLRC to collaboratively and synergistically advance measurement
and analyses issues and their dissemination to fulfill the mission of the Chicago Asian RCMAR. By developing
and disseminating innovative measurement and methodological approaches in concert with other RCMAR
centers, the coordinating center and others, we will help to foster the careers and research of RCMAR
Scholars to elucidate the complexities of Asian aging health disparities. Through addressing methodological
issues in conducting studies of multiple designs, we will increase investigators' scientific capacity to conduct
transformative research and reduce health disparities in Asian communities.

Public health relevance
Project Narrative: Measurement and Analysis Core: Asian communities are heterogeneous in the conceptualization and operational definitions of trauma and resilience constructs. Without sound measurement and analytical approaches, it will be difficult to systematically advance Asian health equity in a sustainable way. In this AnC, we will leverage our rich experience and track-record to rigorously build infrastructure that enables pilot scholar's development and advances the science of trauma and resilience research in Asian older adult populations in an environment that is conducive for success.